Design and Evaluation for Equity Core

CORE B: PROGRAM SUMMARY / ABSTRACT
While there has been much progress in building the evidence to prevent diabetes and its complications, and
notable improvements in quality of care and incidence of vascular complications among people with diagnosed
diabetes over the past 30 years, there is a large unfinished agenda. Identification of people at risk for and with
diabetes, and uptake of prevention programs are suboptimal; and more can be done to achieve recommended
care goals and reduce morbidity, especially among minorities and vulnerable subpopulations. Translation
research, especially health and preventive services research, design, and evaluation can help close gaps
equitably by helping identify how to tailor implementation efforts to better suit target populations and by
generating policy-, program-, and practice-oriented data to inform investments in diabetes. Though there is
plentiful demand in the Southeastern U.S., availability of relevant expertise is limited and fragmented, which is
a barrier for aspiring junior and underrepresented minority (URM) investigators. Core B (Design and
Evaluation for Equity) of the Georgia Center for Diabetes Translation Research (GCDTR) is poised to fill this
void by facilitating access to local, regional, and national datasets (Aim 1); offering accessible, cohesive, and
multi-disciplinary methodological, analytical, and strategic expertise in diabetes translation research (Aim 2);
and helping link research with opportunities for translation and implementation (Aim 3). Core B's collective
expertise, networks and partnerships, and access to key databases that are in high demand make it well-suited
for stimulating high-quality diabetes translation research and uptake among a wide array of stakeholders
(academics, health care, non- and for-profit organizations, and local and federal government). In its first 4
years, Core B has developed a strong culture of multi-disciplinarity, collegiality, continuous learning, and
leverage. Building on these successes, Core B will continue its focus on prioritizing support for junior and URM
investigators. The Core is well-integrated with other GCDTR Cores and Programs and embodies the same
ethos of promoting equity at our institutions, our membership, and in our research. Core Experts will continue
to engage in the GCDTR's catalyst and dissemination activities (Pilot and Feasibility and Enrichment
Programs) and complement the other Cores. Core B Experts will be accessible and active with simple
operating and reporting structures that facilitate more effective and cost-effective science. Core B has
expertise in health services and disparities research, clinical medicine (primary care, geriatrics, endocrinology,
preventive cardiology), nursing, systems design, statistics, analytics, epidemiology, engineering, management,
and economics. Continuing to leverage Core B's collective expertise and resources offers an expedient and
efficient opportunity to advance the field, promoting equity for the increasingly diverse population in the
Southeastern U.S., and informing local initiatives to improve metabolic health in the region.